Exosomes, Microvesicles and Other Extracellular Vesicles

ABSTRACT Support is requested for a Keystone Symposia conference entitled Exosomes, Microvesicles and Other Extracellular Vesicles, organized by Drs. Clotilde Thery, Andrew Hill and Susmita Sahoo. The conference will be held in Banff, Canada from March 9-13, 2021. Extracellular vesicles (EVs), including various sub-types such as exosomes, microvesicles and others, are membranous nanovesicles containing bioactive molecules such as lipids, proteins, RNA and metabolites derived from the cell of their origin. As EVs can carry cell-specific signatures, they can be important components of pathophysiological conditions and may serve as disease biomarkers or therapeutic entities. This program was designed to communicate and disseminate cutting-edge findings regarding extracellular vesicles (EVs) to an audience of researchers and to foster robust interactions among them. This conference will emphasize groundbreaking science on the biological aspects and clinical utility of EVs, the evidence for EVs as biomarkers of disease, and the role of EVs in human disease pathogenesis and their corresponding therapeutic utility. The conference will include presentations from distinguished international leaders and researchers in the field of EV biology. Characterization, tools and technologies, as well as diagnostics and therapeutics, will guide oral and thematically grouped poster presentations. As a relatively new feature, panel discussions at the end of some sessions will allow young investigators additional opportunities to interact with the speakers and obtain a comprehensive understanding of each session topic. Moreover, workshops on the focused aspects of EV research will provide young researchers with a unique opportunity for in depth interaction with the experts. It is anticipated that this conference will present new scientific knowledge including new methodologies and technical approaches to study EVs. One final goal is for new collaboration opportunities and networking opportunities to be forged by participants attending this conference.

Public health relevance
PROJECT NARRATIVE There is growing recognition that extracellular vesicles (EVs), small lipid enclosed carriers of bioactive proteins, lipids, and nucleic acids that are actively released from all cells, play a unique and evolutionarily conserved role in cellular communication. Furthermore, research in this field has exponentially grown and has gained interest from diverse scientific groups, including basic scientists, clinicians, academicians and industry. Therefore, keeping pace with the rate of discovery in this field is challenging and so consequently this conference was developed to bring together researchers with a spectrum of perspectives on these issues with the aim to make a significant contribution to advancing the field of exosomes and microvesicles research to advance treatments in human health and disease.